Colorado's Partnership to Implement Evidence-Based Interventions to Reduce the Cancer Burden

Abstract The University of Colorado Cancer Center (UCCC) and the Colorado Cancer Coalition (CCC) will collaborate to develop regional networks to implement cancer control interventions to reduce cancer disparities in Colorado. UCCC’s catchment area is the State of Colorado and is the only NCI-designated cancer center in the state driving cancer discovery and innovation through its basic to translational to clinical to population science investigations. The CCC is a statewide organization seeking to eliminate the cancer burden in Colorado by engaging, facilitating, expanding, and strengthening the statewide network dedicated to improving Colorado lives touched by cancer. As leaders in the state, the UCCC and CCC will bring key stakeholders from 5 regions in Colorado (Front Range, Eastern, Western, Central Mountain, and the San Luis Valley/Southern regions) to partner and meaningfully reduce the incidence, mortality, and late-stage cancers that disproportionately affect underserved populations. Coloradans affected by cancer disparities would benefit greatly from increased access and uptake cancer control evidence-based interventions (EBIs) across the cancer continuum, but specially to reduce modifiable risk factors (e.g., smoking, human papillomavirus infection, low cancer screenings). Strengthening networks of community stakeholders from primary care and public health holds great promise for the wider implementation of evidence- based interventions and to increase cancer control research in Colorado. Thus, we will convene and support 5 RCNs to build collaboration and the infrastructure needed to bolster cancer control efforts. We have determined cancer disparity counties’ needs and capacity to implement cancer control activities and to conduct research. As the next step, UCCC and CCC will convene the 5 RCNs of key stakeholders to begin planning and implementing cancer control EBIs in disparity counties and to conduct research to study the implementation of EBIs. Each network will have a Regional Planner, an individual or organization, who will oversee the implementation and the short (1-year) and long-term (5-years) evaluation of the initiatives. The planner will also coordinate regional representation in the Colorado Cancer Coalition’s Cancer Task Forces to expand the referral resources and connect smaller regions of the state to the broader coalition efforts towards decreasing the state’s cancer burden. For the second aim, the RCNs will collaborate with UCCC investigators to conduct a pilot project to study the implementation of EBIs relevant to the regional cancer priorities and to affect cancer control targets such as improving HPV vaccine rates, lung cancer screenings, and colonoscopies, among other targets. The projects proposed will use a combination of conceptual frameworks to study the implementation of EBIs, including the Reach, Effectiveness, Adoption, and Implementation, Maintenance (RE-AIM) framework, the Practical Robust Implementation and Sustainability Model (PRISM), and the Consolidated Framework for Research (CFIR), which aid in designing and evaluating the implementation of EBIs to improve the cancer control outcomes targeted.

Public health relevance
Project Narrative: Improving cancer control outcomes among underserved populations decreases disparities in cancer incidence, mortality, and burden that disproportionately affect them. We will convene Regional Cancer Networks (RCNs) from 5 regions of Colorado to engage in the implementation and evaluation of cancer control evidence-based interventions to improve cancer outcomes. The RCNs will be incorporated into the Colorado Cancer Coalition's Task Forces and Steering Committee to achieve the cancer priorities outlined in the Colorado Cancer Plan.